Impact of ecological interactions on mutant fitness and evolution in microbes

Project Summary/Abstract
Microbes acquire an enormous number of new mutations every day in nature, which enables them to rapidly
adapt to environmental changes. At the same time, these microbes are often dependent on interactions between
species and strains, especially the exchange of nutrients (cross-feeding). Our ability to predict evolution of mi-
crobes in different ecological environments is valuable for treating infectious diseases — for example, anticipating
if and how fast a pathogen will evolve resistance to a treatment — as well as for designing personalized medicine
based on an individual’s evolving microbiome. The overall goal of our lab’s research is therefore to understand
the feedback between these evolutionary and ecological processes in microbial communities. A particular chal-
lenge in this field is our ability to quantitatively predict the effects of mutations on fitness, and how those effects
vary across ecological environments. The distribution of fitness effects — the set of fitness values for all spon-
taneous mutations available to a population — is a key input to predicting how a population will evolve, and its
variation across environments can reveal unknown gene functions. However, since we cannot empirically mea-
sure the fitness of mutations across all possible environments, it is crucial that we develop general principles for
how mutant fitness changes across these environments to predict evolution. We need to know these rules, for
example, to predict whether cross-feeding certain nutrients is likely to make a species adapt more slowly or more
quickly, and how it changes the genes and molecular pathways under selection. In the next five years, our lab
seeks to develop principles by which ecological interactions affect mutant fitness by addressing three questions:
1) Do different kinds of interactions have different effects on mutant fitness? 2) Do different kinds of mutants
respond differently to interactions? 3) What mechanisms cause interactions to alter mutant fitness? We will focus
on Escherichia coli auxotrophs that allow us to engineer defined cross-feeding interactions, combined with DNA
barcoding for generating and tracking high-throughput mutant libraries. We will experimentally measure the effect
of cross-feeding different types of nutrients (amino acids, vitamins, carbon intermediates) on mutant fitness, as
well as the effect of cross-feeding on different types of mutants (gene knockouts from transposon insertions vs.
spontaneous mutations from an evolution experiment). In parallel we will use whole-genome metabolic models to
make predictions for these experiments and investigate the underlying mechanisms. In particular, we seek to test
how metabolic cheating and changes in nutrient limitation mediate the effect of cross-feeding on mutant fitness.
Our long-term goal is to apply the principles we learn from this laboratory system to complex, naturalistic com-
munities that involve a range of ecological interactions. Our work on this problem will contribute toward predicting
microbial evolution across ecological environments as well as helping discover new functions of genes, especially
secondary activities that arise under nutrient conditions not commonly tested in the lab.

Public health relevance
Project Narrative Interactions between microbial species, such as the exchange of nutrients, are pervasive in the human body and other natural environments, and they have been found to significantly alter the ability of microbes to adapt to environmental changes such as antibiotic treatment. This project will develop general rules for how these interactions shape the fitness of new mutations, especially the underlying molecular and cellular mechanisms. These principles will help us better predict the evolution of microbes in nature and discover unknown functions of their genes.